Diagnostic and interventional cardiovascular catheterization

Cardiac and vascular catheterization services are provided to patients of NHLBI and other institutes at NIH Clinical Center based on clinical need. This includes off-hours emergency cardiovascular care. This also includes invasive cardiovascular services required for the conduct of invasive and non-invasive protocols from collaborating investigators.

This year clinical care was provided to patients suffering COVID-19 at NIH Clinical Center.

We provide consultative outpatient inpatient cardiovascular care, in coordination with the NHLBI consultative cardiology service. We also contribute vascular medicine consultative services and non-invasive imaging services.

We provide consultative image guidance, for example image guidance reports to help centers safely perform transcaval access, LAMPOON, or BASILICA procedures.

Part of our motivation is to provide clinical cardiovascular care. Part of our motivation is to maintain and enhance the skills of staff physician, nurse, technologist alike required to provide excellent investigational care.

We also travel to outside medical centers through close collaboration to bring outside advances in catheter intervention, specifically in the field of structural heart intervention, back into the NHLBI Division of Intramural Research. In addition, we travel to outside medical centers to teach techniques developed at NIH, such as transcaval access to the aorta to enable transcatheter aortic valve replacement, LAMPOON, and BASILICA. Two examples include the NHLBI collaborative research program at Emory University Hospital in Atlanta GA, and the NHLBI collaborative research program at Medstar Washington Hospital Center in Washington DC.